A longitudinal cohort study of Plasmodium vivax relapses in Central Africa

PROJECT SUMMARY
Title: A longitudinal cohort study of Plasmodium vivax relapses in Central Africa
Plasmodium vivax (Pv) infections caused by relapse are an important cause of morbidity and source of
transmission in malaria endemic areas. Relapses contribute significantly to the challenges in controlling and
eliminating vivax malaria. Historically, vivax malaria was considered rare or absent in Central and West Africa
because of the dominance of Duffy-negative individuals, who lack expression of the Duffy Antigen Receptor for
Chemokines (DARC) Pv required for erythrocyte invasion. However, there is growing evidence
documenting Pv cases across different parts of Central and West Africa, beyond its endemic range in the Horn
of Africa. Prior studies provide compelling evidence that Duffy negativity is not a definitive barrier to Pv invasion
and the potential of widespread Pv transmission within Africa. Relapses are known to account for a high
proportion of recurrent Pv infections across diverse geographic locations. In Africa, Pv is understudied and at
the public health front-end, Pv infections are vastly overlooked in large parts of Africa. Despite numerous
reports of Pv cases in Duffy negatives from West and Central Africa, most malaria cases in health facilities are
considered as Pf and treated with artemisinin-based combination therapy (ACT). Information on the frequency
and transmission potential of Pv relapses in Duffy negative Africans are largely unknown. This R21
application will address 1) what proportion of Pv infections has relapses, 2) how often (i.e. periodicity) relapses
occur, 3) are relapse parasites genetically more diverse than those in primary infections, and 4) does relapse
infection lead to transmission. Because relapsing infections are important drivers of transmission of Pv
malaria, the proportion of recurrences caused by relapse and gametocyte carriage of relapse infections are
critical to existing malaria diagnosis and antimalarial treatment regimens in Central/West Africa. Our prior
study in Buea of Cameroon showed ~10% of febrile malaria cases and ~15% of asymptomatic community
samples being Pv and all were from Duffy-negative individuals. This study will employ a longitudinal design to
follow up a cohort of Pv-infected individuals with ACT and without antimalarial treatment to systematically
examine relapse biology of Pv in Duffy-negative individuals in Cameroon, an understudied region.

Public health relevance
PUBLIC HEALTH RELEVANCE Recent studies indicated that Plasmodium vivax (Pv) can infect Duffy-negative individuals and cause malaria symptoms, but the frequency and transmission potential of Pv relapses in Duffy negative Africans are largely unknown. This study will determine the rate, periodicity, and gametocyte carriage of Pv relapses and the effect of artemisinin-based combination therapy on relapses in Duffy negative individuals through a longitudinally study, filling a major knowledge gap in Pv relapse biology in Duffy-negative Africans, which has never been performed. Because relapse infections are important drivers of transmission of Pv malaria, findings of this research will emphasize the need for precise diagnosis and effective treatment of Pv malaria in large parts of Africa where vivax malaria is on an upward trajectory.